A Portable low-cost, Point of Investigation CapCell Scope to Image and Quantify the Major Axes of Metabolism and the Associated Vasculature in In vitro and In vivo Biological Models

Summary
Interest in metabolism and the vascular microenvironment continues to grow in a broad range of disciplines
including neuroscience, cardiovascular biology, and the field of cancer research. Given their clinical importance,
there are surprisingly few techniques available that can provide a systems-level view of these hallmarks together in
vivo. Though there are many bench-top microscopes and metabolic tools available to provide exquisite resolution
and contrast for metabolic or vascular imaging, they often require researchers to transport animals to specialized
facilities and this limits access for high frequency imaging, these systems require extensive training and often have
fields of view (FOV), resolution and wavelengths that fits only the most common use cases (in the case of optical
microscopy systems). Our goals are to develop and validate a point-of-investigation metabolic and vascular imaging
system and corresponding algorithms that will democratize access to imaging for cancer research in individual
cancer pharmacology labs. The capabilities of our system will be demonstrated through imaging of metabolism,
vascular function, and architecture at a spatial resolution that can visualize proliferative, regressive, residual, and
recurrent disease in a breast cancer model. Our technique could provide a comprehensive understanding how the
metabolic characteristics of tumors impact therapeutic outcome and can be used in a wide range of cancer
pharmacology applications to improve the effectiveness of cancer therapy. The specific goals of this proposal are to
develop an low-cost, portable, user friendly, CapCell scope to image key metabolic and vascular endpoints
simultaneously with a wide range of FOVs and resolutions (Aim 1), demonstrate that this technology provides
comparable information and can complement established methods in well-established murine tumor models of
breast cancer (Aim 2), and validate the technology on GEM model derived mammospheres and in vivo mammary
window models of GEM model derived tumors (Aim 3). This proposal sets the foundation for translating our
technology to patient-derived xenograft (PDX) models and patient-derived organoids, which have been shown to be
able to faithfully recapitulate many of the micro-environmental features of patient tumors, allowing us move our
technique forward towards translational pharmaceutical research.

Public health relevance
PROJECT NARRATIVE The goal of our proposed program is to develop and validate a low-cost, portable, user friendly, multi-parametric CapCell Scope and novel automated image processing algorithms and experimental strategies to quantify metabolic and vascular endpoints at a spatial resolution that allows for visualization of metabolic and vascular reprogramming in biological tissue. Metabolic and vascular reprogramming is key to biological process in health tissue and many disease processes including cancer. Our technique fits within the broader framework of existing metabolic assessment and provides a systematic way to connect in vitro studies to whole body imaging.